Young Minority Scientists in the Field of Cancer Research

Abstract
The American Association for Cancer Research (AACR) requests renewal of support for the project
“Young Minority Scientists in the Field of Cancer.” These funds will provide Minority Scholar in Cancer
Research Awards to support the participation of early-career underrepresented scientists from NIH-
recognized minority populations at high-caliber national scientific conferences organized by the AACR.
AACR conferences present unique opportunities to interact with the world’s leading experts and discuss
the latest findings in rapidly developing areas of cancer research. By attending an AACR conference,
attendees will advance their understanding of cancer and be exposed to the most cutting-edge research
in the field. This project is an essential component of a multi-level program instituted by the AACR to
address the problem of underrepresentation of minorities working in cancer research and biomedical
science.
The Minority Scholar in Cancer Research Awards program exposes early-career minority scientists to the
most current groundbreaking cancer science and medicine through their participation in AACR Annual
Meetings and Special Conferences. In addition to their exposure to cancer research, scholar awardees
also gain access to mentoring and networking opportunities with experienced investigators, career-
building showcases of their achievements, and important professional development guidance. These
awards are given annually to minority graduate students, medical students, residents, and clinical and
postdoctoral fellows to support their participation at AACR Annual Meetings or Special Conferences.
These awards have been generously supported through this R13 funding mechanism from 1985-2022.
The AACR is deeply appreciative to the National Cancer Institute (NCI) for 37 years of supporting
minority investigators in cancer research and looks forward to continuing the success of this program for
the period 2023-2028.

Public health relevance
Public Health This project is a pivotal initiative by the American Association for Cancer Research to address the challenges of minority underrepresentation in cancer research, to support an increasing number of minority investigators to contribute, thrive, and to gain health equity in the field of cancer research. Minority cancer researchers have many unique roles to play in cancer research, including adding a diverse voice to this field of study with the promise of producing innovation and mentoring opportunities for future minority students. One of the most important results of the program is to improve outcomes for minority and medically underserved patients. Minority research scientists have the potential to be more successful in balancing the diversity of clinical trial subjects and more successful in inspiring the trust of subjects. Because of sensitivity to cultures and even the locations of targeted populations, dedicated minority researchers also hold promise for succeeding with behavioral interventions that require outreach to minority communities.